Computational framework to investigate the inorganic ion transporters

Abstract
Transmembrane transporters play a critical gatekeeper role in determining and controlling the intracellular
concentration of ions, nutrients, toxins, or drugs in all cells. Our current knowledge of transmembrane
transporters is mainly gained by extensive studies on proton, alkali, and alkaline earth metal cation transporters,
while the transport of anions and transition metals is overlooked despite their significantly different properties.
The (dys)function of anions and transition metal transporters is now linked directly to resistance against
antibiotics, chemotherapeutic agents, and metal-based drugs and is associated with many human diseases such
as cystic fibrosis, myotonia, Menkes, and Wilson’s diseases. Despite their biological importance, the underlying
biochemical and biophysical basis at the atomic and molecular level for the selectivity, transport mechanism,
stoichiometry, and conformational dynamics of anion and transition metal transporters remain largely elusive.
The long-term research goal of my laboratory is to fill this gap in the field of transmembrane transporters by
combining different advanced computational approaches.
To this end, this MIRA application aims to investigate two phylogenetically unrelated families of bacterial fluoride
export protein: CLCF F-/H+ antiporters and fluoride ion channels, and P1B-type ATPases which transport Cu+,
Cu2+, and Zn2+ across cellular membranes. My laboratory has established a computational platform by integrating
different advanced computational approaches to study various complex biological systems including
transmembrane proteins. In the proposed research, we will combine quantum, molecular, and statistical
mechanics, and advanced polarizable force field development and will integrate our advanced computational
techniques with experimental and co-evolutionary investigation to 1) monitor the dynamics and local
conformational changes of the transmembrane transporters, 2) characterize the selectivity filter and coordination
chemistry of the transported ions, 3) identify contributing residues in ion transport, 4) introduce mutations that
potentially alter the ion selectivity, 5) find promising inhibitors, 6) determine transport stoichiometry and counter-
transport ions, and 7) map out the transport mechanism. Built upon our experience, we will focus on the inclusion
of explicit polarization in modeling transmembrane transporters because ions in particular anions and transition
metals have high polarizability. We will provide a comprehensive comparison between the models developed
with polarizable and non-polarizable force fields. The developed polarizable force field for lipid molecules will
have a novel feature to make it transferable to other studies of biological systems.
The proposed project will target a neglected aspect in studying transmembrane transporters, will establish an
innovative computational framework to study these complex systems, and will train a new generation of
biomedical scientists. The outcomes of the proposed project will address the emerging global challenge of
antibiotic and metal-based drug resistance and aid bioengineers in designing novel effective therapeutic agents.

Public health relevance
Public health relevance statement Transmembrane transporters play vital roles in cell physiology, diseases, and therapy; however, their insertion into lipid bilayers makes them challenging systems to investigate computationally and experimentally. Among transmembrane transporters, alkali and alkaline earth metal cation transporters received significant attention, while the anion and transition metal transporters have not. The proposed project will establish a computational framework to systematically investigate the complex anion and transition metal transporters to uncover the underlying biochemical and molecular basis for ion selectivity and transport mechanism.